Training program addressing the multilevel factors that affect pregnancy-related and pregnancy-associated morbidity and mortality disparities

The Training Component will prepare scientists, including early-stage investigators and other junior scien-
tists, students, and postdocs from under-represented backgrounds, to conduct research to that will help us un-
derstand and address multilevel factors causing PRAMM disparities. As our projects address PRAMM disparities
at the patient, community, provider, and systems levels, so too will our training program. The overall goal of the
Center’s Training Component is to engage and prepare junior investigators, with a focus on early-stage investi-
gators from backgrounds or identities currently underrepresented in the health sciences, to conduct research
that addresses the biological, behavioral, environmental, and structural determinants of PRAMM and disparities.
The Training Component will leverage the expertise and networks of Center investigators and community
partners, who bring a broad range of expertise in community-engaged research methods, developing and testing
multilevel interventions, dissemination and implementation science, analysis of population-level data, random-
ized trial designs, factorial designs, quasi-experimental studies, and analysis of claims data. Center investigators
also bring expertise on using mobile health to reduce disparities and substantive knowledge and experience
testing interventions for understudied causes of PRAMM disparities, including partner violence, suicide, sub-
stance use, and other co-occurring conditions. The College of Human Medicine at Michigan State University
offers an ideal environment for this training program because of its emphasis on community-engagement and
health disparities, its reach across multiple locations in Michigan (Flint, Grand Rapids, Lansing/East Lansing,
and Northern Michigan) and its partnership with Henry Ford Health System in Southeast Michigan. We will pur-
sue the following Specific Aims.
1. Engage and train Collaborating Scholars through one-on-one mentoring, hands-on experiential learning,
and structured training, with a focus on early-stage and underrepresented investigators.
2. Provide opportunities for other early-stage and junior investigators, students, and postdocs to learn
from participating in PRAMM disparities research by including them in Center projects.
3. Provide a set of didactic opportunities focused on understanding and addressing the multi-level de-
terminants of PRAMM to the entire Research Community, i.e., Investigators, staff, Community Partners,
Collaborating Scholars and other students, postdocs, new investigators, and interested stakeholders
4. Leverage an extensive network of existing training opportunities that include courses, seminars, and
trainings from across the Michigan State University colleges in East Lansing and Flint, Michigan, other Com-
munity Partner organizations, and other sources as appropriate